SAFETY OF TOPICAL TACROLIMUS OINTMENT FOR PEDIATRIC ATOPIC DERMATITIS PATIENTS

To evaluate the safety and efficacy of tacrolimus ointment when used continuously or intermittently, for up to one year, in pediatric patients with moderate to severe atopic dermatitis.